Genotypic and phenotypic approaches to subtype individuals with coronary heart disease

PROJECT SUMMARY
Traditional genome-wide association studies (GWAS) have typically overlooked the heterogeneity in coronary
heart disease (CHD), which could be one of the reasons for the gap between current risk assessment models
and a personalized approach for CHD prevention and treatment. To bridge this gap, I will focus on the
development of CHD without prior elevated traditional risk factors in diverse populations. The pooled
cohort equations (PCE) are recommended by the American College of Cardiology and the American Heart
Association to guide primary CHD prevention in clinical practice. However, the PCE’s limited portability to other
ancestries, small sample sizes, and a limited set of variables available contribute to its imprecise nature in risk
assessment. Patients who develop CHD without prior elevated traditional risk factors, thus having low PCE
scores (defined as CHDlowPCE), may have different underlying mechanisms not captured by traditional risk
factors in the PCE, and therefore require a more in-depth investigation for accurate CHD prediction.
To address the knowledge gaps, I propose to leverage advanced statistical methods, including polygenic
risk scores (PRSs) and machine learning (ML) algorithms, in diverse populations to better understand the
physiological mechanisms underlying CHDlowPCE. I aim to identify novel genetic variants that are associated with
incident CHD risk without prior elevated traditional risk factors (CHDlowPCE), prioritize
potentially causal variants,
and optimize multi-ancestry PRSs for CHD (Aim 1). I will create a novel score representing increased incident
CVD risk and decreased traditional risk factors and perform multi-ancestry GWAS on it. I will also prioritize
potentially causal variants and genes in identified loci and prioritize relevant biological system. In addition, I will
build genome-wide PRSs that combine common and rare variants from summary statistics and evaluate their
performance in assessing CHDlowPCE. In parallel, I aim to identify non-traditional risk factors for incident CHDlowPCE
using EHR data and ML methods (Aim 2). This involves conducting a risk factor search using clinical features in
the EHR data and a random forest-based ML framework, and evaluating the causal effect of novel risk factors
on CHD using Mendelian Randomization approaches. Lastly, I will utilize these findings to subtype CHD patients
based on genetic and phenotypic risk factors (Aim 3). I hypothesize that subsets of genetic loci that group based
on their association signatures and pathway-based PRSs will shed lights on different disease mechanism and
define subgroups for CHD patients in diverse populations.
In summary, this project will enhance the CHD risk assessment by systematically evaluating the genetic
and non-genetic risk factors underlying the misclassified CHD risk in diverse populations, and subtype
patients based on CHD pathophysiology.

Public health relevance
Project Narrative Remaining to be the leading cause of mortality worldwide, the risk assessment tools and prediction models for coronary heart disease (CHD) are suboptimal. The proposed research aims to improve the risk assessment of future CHD by leveraging novel genomic approaches and advanced machine learning techniques in EHR-linked diverse populations. The results will lay the groundwork for personalized prevention and treatment of CHD for all.